EFFECTS OF HYPERINSULINEMIA ON RENAL HEMODYNAMICS IN PATIENTS WITH IDDM &NIDDM

This study is designed to test the hypothesis that insulin modulates renal hemodynamics by altering the production of endothelium-derived vasoactive substances. To test this hypothesis we will assess basal and stimulated renal hemodynamics at different steady state insulin levels. We will also measure urine and plasma levels of endothelin-1 and nitrate (a stable metabolite of nitric oxide) at different steady state insulin levels.